Intravaginal device for the treatment of pelvic pain and dyspareunia in female cancer survivors

Summary: More than half of female cancer survivors will experience chronic pelvic pain and dyspareunia (painful
intercourse) due to their cancer treatments. As the number of cancer survivors continues to grow, so too will the
number of women in need of effective treatments for this life-altering condition. Pelvic floor physical therapists
currently use several different devices during in-clinic and at-home therapy (vaginal dilators, pelvic wands,
vibration devices) but these devices are unregulated, lack appropriate ergonomics, and do not consider
comprehensive functionality, patient-specific needs, and the physical challenges common to cancer survivors.
Survivors seek an effective multimodal solution that also provides them with the knowledge, skills, and
confidence to advocate for their own sexual health. Cervu, Inc. is developing a patent-pending intravaginal device
for the highly individualized needs of female cancer survivors that is uniquely designed for dilation, vibration,
myofascial release, and trigger point massage therapies. To date, prototype form factor designs have been 3D
printed and mailed to patients and providers through multiple rounds of user testing, resulting in down-selection
to a candidate design for further development. The objective of this Phase 1 SBIR proposal is to confirm feasibility
of function within the confines of the candidate form factor, and to acquire further user feedback prior to design
freeze for first-in-human studies. Aim 1. Develop and validate a functional alpha prototype. We will
collaborate with design and manufacturing partners to (1) resolve remaining design questions such as selecting
appropriate materials, specifying eccentric rotating mass vibration motor and electrical components, and
finalizing the handle-dilator attachment mechanism; (2) manufacture a minimum viable product; and (3) validate
function agreement with specifications through extensive bench testing. Goals: (1) Device meets form and
function specifications including handle and dilator size and curvature tolerance, handle pitch and roll range of
motion, vibration frequency, charging speed, visual indicators, dilator durometer, handle attachment/detachment
force, weight distribution, and quality consistency; (2) Production of 5 alpha prototypes that meet or exceed
specifications. Aim 2. Demonstrate ability of alpha prototype to meet user needs. We will validate design
form agreement through formative user testing in 10 total subjects including pelvic floor physical therapists and
female cancer survivors with dyspareunia. Subjects will receive prototypes and will be interviewed on the specific
device features as well as anticipated ability to perform therapy. Goal: More than 80% of users rate each feature
≥ 3 on a 5-point Likert scale. The proposed work is expected to demonstrate that a functional device can be
implemented within a form factor that ensures user acceptance. Impact: This device has the potential to
transform dyspareunia treatment, one of the most common conditions affecting quality of life in female cancer
survivors.

Public health relevance
Narrative: Female patients surviving cancer consistently report that pelvic pain and dyspareunia (pain with sexual intercourse) are among their biggest quality of life concerns. Current solutions are largely unregulated, lack appropriate ergonomics, provide only a single form of therapy, and do not provide comprehensive progress tracking for the patient and provider. This study is designed to test the feasibility of a multi-functional intravaginal device for dilation, vibration, myofascial release, and trigger point massage therapies uniquely designed for the needs and physical challenges common to cancer survivors, with the goal of improved treatment, patient well- being, and quality of life.